Using a SMART design to evaluate remotely delivered, culturally tailored weight loss interventions among Latina breast cancer survivors

ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOSI
NOT-CA-24-032. The proposed research supports the specific activities and aims of R01CA270441, “Using a
SMART design to evaluate a remotely delivered, culturally tailored weight loss interventions among
Latina breast cancer survivors” (PI: Greenlee). Breast cancer (BC) is the leading cause of cancer death
among US Latinas. Latinas are at high risk of obesity and obesity-related diseases, which are associated with
poorer cancer outcomes. Latina BC survivors are underrepresented in cancer research and there is a
significant lack of effective interventions to address the diverse needs of Latina BC survivors to achieve and
maintain a healthy weight. We were recently funded by NCI to conduct a two-stage sequential multiple
assignment randomized trial (SMART) testing 12-month adaptive culturally-tailored Diabetes Prevention
Program (DPP)-based weight loss interventions in a geographically diverse group of Latina BC survivors in
Washington State and California recruited via NCI’s Surveillance, Epidemiology, and End Results Program
(SEER) registries (n=640), called the ¡Vida! trial. With this Administrative Supplement, we propose to initiate
additional baseline data collection to assess multi-level factors that may contribute to the success and/or failure
of Latina BC survivors engaging with the ¡Vida! program and their weight loss at 12 months. Proposed new
data collection measures will include social determinants of health [SDOH, measured via the 27-item Centers
for Medicare and Medicaid Services Accountable Health Communities (AHC) Health-Related Social Needs
Screening Tool (HRSN) assessing housing instability, food insecurity, transportation problems, utility help
needs, and disabilities] and neighborhood characteristics (built environment, safety, noise, litter, neighbors,
and walkability measured via an adaptation of a 27-item questionnaire previously used in the Kaiser
Permanente Northern California Pathways Study cohort of BC survivors). Engagement will be assessed via
program attendance and use of digital resources throughout the 12 month trial period. Weight loss will be
assessed via percent weight loss at 12 months. Specific Aims are: 1) To solicit input from the ¡Vida!
Community Advisory Board on the HRSN and neighborhood characteristics assessment tools, and culturally
adapt the tools as needed; 2) To assess SDOH as moderators of ¡Vida! program engagement (Stages 1 and
2) and weight loss at 12 months in a diverse population of Latina BC survivors; and 3) To assess neighborhood
characteristics as moderators of ¡Vida! program engagement (Stage 1 and 2) and weight loss at 12 months in
a diverse population of Latina BC survivors. Results will provide data on how SDOH and neighborhood
characteristics affect within-group engagement with and weight loss effects of a culturally-tailored DPP-based
weight loss program in Latina breast cancer survivors.

Public health relevance
PROJECT NARRATIVE Breast cancer is the leading cause of cancer death among US Latinas. Latinas are at high risk of obesity and obesity-related diseases, which are associated with poorer cancer outcomes. In a new trial testing culturally- tailored weight loss interventions in Latina breast cancer survivors, we will add new measures to assess social determinants of health and neighborhood characteristics at trial enrollment. We will study how social determinants of health and neighborhood characteristics affect how Latina breast cancer survivors engage with the culturally-tailored weight loss programs and how much weight they lose.